Antibody feedback on B cell response to vaccination

ABSTRACT
Since 2020, over 600 million COVID-19 vaccinations and 500 million influenza vaccinations have been
administered in the United States. These vaccines have saved millions of lives by inducing the differentiation
and maturation of antigen-specific B cells into antibody-secreting cells, resulting in the generation of high-affinity,
protective antibodies. However, little is known about how these antibodies could regulate the ongoing B cell
response or subsequent responses to vaccination. Notably, a durable B cell response that produces long-lived
antibody-secreting plasma cells and poised memory B cells relies on the processes of affinity maturation and
clonal expansion, which occur in anatomical structures called germinal centers (GCs). This proposal aims to
provide insight into antibodies' role in regulating germinal center responses. This is a particularly important
concept for vaccinations that occur in the context of pre-existing humoral immunity, as in seasonal influenza or
COVID-19 booster vaccinations. In Aim 1, the hypothesis of antibody feedback on vaccine-elicited GC B
responses will be tested in a newly generated mouse model where IgG1 antibody secretion can be inducibly
blocked. The GC response's quality, magnitude, and duration will be characterized in primary and heterologous
boost systems. In Aim 2, the same overarching hypothesis will be examined in a human rabies vaccination
model. Here, the impact of polyclonal rabies immunoglobulin administration on vaccine-induced GC B cells will
be examined for epitope specificity, magnitude, and kinetics changes. Additionally, GC products, long-lived
memory B cells, and bone marrow plasma cells will be characterized in the presence and absence of exogenous
antibodies. The overall goal of this proposal is to test hypotheses of antibody feedback on GC B cells in
complementary systems that combine unique mechanistic probing in mice with authentic human vaccine
responses. These findings will have broad public health implications for the millions of vaccinations administered
yearly in the United States.
During the fellowship, the applicant will acquire fundamental skills that will serve as a steppingstone toward
becoming an independent investigator in vaccine research. This will include developing expertise in both rodent
and human vaccination models. As described in the proposed training plan, the applicant will be supported by
Drs. Ellebedy and Diamond who have demonstrated experience in B cell vaccine responses and mentorship of
scientific trainees. With Washington University's track record of excellence in training immunologists and
physician-scientists, the applicant will be well-equipped for success in their training towards becoming a
physician-scientist.

Public health relevance
NARRATIVE The development of more efficacious vaccinations relies on a thorough understanding of the host immune responses to vaccinations, including intrinsic regulation. The proposed work will provide a fundamental understanding of antibodies as a critical regulatory mechanism of B cell responses to vaccination. These studies have the potential to impact public health through the design and implementation of future vaccination strategies.